Investigation of New Molecules in Tooth and Root Developmental Anomalies

Project Summary/Abstract
Short Root Anomaly (SRA) is a dental anomaly with major adverse clinical outcomes in orthodontics. SRA
is a developmental disorder that affects tooth root formation resulting in short roots and unfavorable root to crown
ratios. In addition, these patients have an increased risk of root resorption, a serious complication in individuals
undergoing orthodontic treatment. The causal gene(s) for SRA remain largely unknown. The long-term goal of
this study is to develop a body of knowledge about the critical genes guiding tooth root development that may
be used to enhance diagnosis and developf novel therapies for SRA. The overall objective of this proposal is to
study the human genotype-phenotype correlation in SRA patients and evaluate the role of SRA associated genes
during tooth root formation. Our preliminary studies have identified a mutation in the Histone Cluster 1 H1 Family
Member C (H1C) gene associated with SRA. Our central hypothesis is that the H1.2 protein (encoded by the
H1C gene) is expressed at key stages of root development; is regulated by NFIC, the root master gene; and that
altering its expression in vitro will dysregulate other signaling molecules involved in root formation and elongation.
We further hypothesize that H1C mutation relates to a localized SRA phenotype and that mutations in additional
genes will contribute to the clinical dental variations of SRA. We will achieve our objective following two specific
aims. First, we will carry out in vitro studies of how H1C, the identified SRA associated gene, relates to regulatory
pathways critical for tooth root formation and elongation. Second, we will correlate the dental phenotype of SRA
patients with known genotype and identify new genes associated with familial SRA. Discovery of novel genes
involved in the pathogenesis of SRA will broaden our knowledge about the regulatory pathways of root formation.
Our data will permit creation of novel animal models that in the future can serve to develop targeted clinical
therapeutics to rescue the root length of the permanent dentition. It will also be of direct benefit for the counseling,
diagnosis, and clinical treatment of orthodontic patients, especially those with a high risk for root resorption.
These biomarkers may be used to shed light on how SRA predisposes patients to root resorptions. Finally, these
studies will facilitate the “bench-to-bedside” transition, from laboratory experiments through clinical trials to point-
of-care patient applications implemented through Precision Dentistry.

Public health relevance
Project Narrative In this project we will investigate new molecules in root developmental anomalies such as Short Root Anomaly (SRA), a poorly understood genetic disorder characterized by short dental roots with significantly reduced crown to root ratios. Our goal is to examine genetic mutations associated with this disorder and delineate the mechanism by which they contribute to altered root formation. Information gleaned from this work may be used in establishing biomarkers for SRA as well as the generation of future studies focusing on therapeutic interventions for prevention and management of this disorder.